VENLAFAXINE ER CAPSULES FOR CHRONIC PAIN ASSOCIATED WITH DIABETIC NEUROPATHY

To evaluate the efficacy, safety, and tolerance of venlafaxine extended release (ER) capsules in relieving pain associated with diabetic neuropathy. Multicenter, double-blind, randomized, placebo-controlled study.